Stress regulation of neurotransmission

Project Summary
The long-term goal of the proposed research is to identify the mechanisms by which bidirectional
communication between the nervous system and the intestine regulates organism-wide responses to
oxidative stress through regulated neuropeptide release. Oxidative stress plays a critical role in cognitive
dysfunction and neuronal death associated with neurodegenerative diseases, but little is known about the
physiological roles that reactive oxygen species play as signaling molecules in the brain. My laboratory
uses the model C. elegans to study new signaling pathways that modulate neurotransmitter release. We
have identified a role for hydrogen peroxide as a signaling molecule that positively regulates the secretion
of specific neuropeptide-like proteins from dense core vesicles through sulfenylation of dense core vesicle
(DCV) release factors. We found that the regulated release of these neuropeptides activates the
antioxidant transcription factor SKN-1/Nrf2 in the intestine. Here we seek to uncover the molecular
mechanisms by which hydrogen peroxide regulates DCV release, and how, in turn, neuropeptide signaling
activates the antioxidant response. This study will reveal novel mechanisms underlying ROS regulation of
DCV secretion and it will provide fundamental insights into how redox homeostasis is achieved through
gut-brain signaling, and may therefore have direct relevance for the development of strategies to treat
neurodegenerative diseases whose progression is associated with unregulated ROS signaling.

Public health relevance
Project Narrative Inter-tissue communication is essential for organismal homeostasis. Our research is focused on the fundamental mechanisms by which bidirectional communication between the nervous system and the intestine regulates antioxidant activity through neuropeptide signaling. Our research will uncover new mechanisms by which reactive oxygen species regulate neuropeptide secretion, which may lead to the development of new therapies for neurodegenerative diseases linked to defective antioxidant homeostasis.